FACTORS INFLUENCING THE DURATION OF BREASTFEEDING IN URBAN MOTHERS

In summary, our study confirmed that Depo Provera contraception immediately postpartum has no detrimental effect on lactation. Other studies are needed to address the issue of a possible positive effect of Depo Provera on lactation. We found no statistically significant difference between groups when testing for a 20% difference in lactational performance. However, larger samples may demonstrate a statistically significant beneficial effect of Depo Provera on lactation.